The BAF chromatin remodeling complex in experience-induced neuronal gene transcription and synapse maturation; implications for autism spectrum disorders

PROJECT SUMMARY
Neurodevelopmental disorders (NDDs), especially autism spectrum disorders (ASD), are alarmingly
prevalent among our children. Recent genome-wide studies suggest a strong correlation between ASD and
loss-of-function mutations in genes encoding subunits of a particular chromatin remodeling complex, called
the Brahma Associated Factor (BAF; alias, mSWI/SNF). However, despite such strong correlation, the
precise role(s) of the neuronal BAF (nBAF) complex in brain development-related gene transcription remains
largely unclear. In response to the NIH funding opportunity titled, ‘Cellular and Molecular Biology of Complex
Brain Disorders’ (PAR-24-025), this project is designed to elucidate neurodevelopmental functions of
SMARCC2 (fundamental biology), a high confidence ASD candidate gene product of the BAF complex. In
working with SMARCC2, our project will organically extend to other subunits of the BAF complex, many of
which are also implicated in NDDs. SMARCC2 and several other members of the BAF complex feature
unstructured Intrinsically Disordered Regions (IDR), which will be the focus of this study. Our central
hypothesis is: ‘In maturing neurons, the nBAF complex drives RNA Pol2 productive elongation (molecular
role), and thereby synapse maturation (cellular role) via IDR-mediated multivalent interactions’. This
hypothesis will be tested via two specific aims: 1) determine if nBAF and its core subunit SMARCC2
mediates RNA Pol2 elongation via IDR-dependent multivalent interactions and liquid-liquid phase
separation (LLPS), and 2) determine if the nBAF complex, via transcription of synapse-related genes,
regulates synapse maturation. We will use pharmacological nBAF complex inhibitors and degraders, RNAi
of key BAF subunits, and genetically encoded expression of mutated BAF subunits to perform studies both in
vitro and in vivo. Taken together, this study will generate valuable insights into nBAF complex functions and
epigenetic mechanisms driving normal and altered ASD-related neurodevelopment, which will fill in the
knowledge gap between BAF mutations and their outcomes, such as ASD. Our findings will also have
broader implications in other fields, such as cancer, where BAF subunit mutations are quite common.

Public health relevance
PROJECT NARRATIVE Recent studies have revealed frequent involvement of mammalian Switch/Sucrose-Nonfermentable (mSWI/SNF; alias, BAF) chromatin-remodeling complexes in neurodevelopmental disorders, such as autism spectrum disorders (ASD) and intellectual disabilities. However, the exact function of the BAF complex during neurodevelopment remains unclear, which in turn, discourages development of therapeutics. In the current study, we will reveal molecular roles of this complex in brain development-related gene transcription to gain insights into ASD-related BAF functions, thereby paving the path for future therapeutic interventions.